Abiological Enzymatic C–H Functionalization for Bioactive Molecule Construction and Diversification

Project Abstract (parent award R01GM138740: Abiological Enzymatic C–H Functionalization for Bioactive Molecule Construction and Diversification) Advances in molecule construction and diversification expedite drug discovery and development. Given the ubiquity of C–H bonds in molecules, methods to selectively convert them into functional groups represent one of the most attractive strategies to introduce diversity efficiently and enable rapid molecular construction. Despite significant advances, however, directly and selectively functionalizing complex molecules bearing multiple stereocenters and delicate functional groups remains a major challenge. Creative use of enzymes to perform new-to-nature C–H functionalization reactions can greatly accelerate such processes, while providing sustainable and more selective alternatives to currently used stoichiometric methods or noble metal catalysts. We propose to start from enzymes that derivatize complex bioactive molecules via C–H hydroxylation and engineer them by directed evolution to perform abiological C–H unctionalization to furnish new C–C bonds or C–N bonds. We envision that these efforts will establish a versatile biocatalytic platform that will provide rapid access to derivatives of complex molecules with selectivity and efficiency unattainable by current synthetic approaches. This work will also illustrate evolutionary innovation mechanisms and the rapid acquisition of novel genetically encoded functions.

Public health relevance
Project Narrative (parent award R01GM138740: Abiological Enzymatic C–H Functionalization for Bioactive Molecule Construction and Diversification) Cytochrome P450 enzymes, which in nature afford C–H functionalization reactions (hydroxylation), will be repurposed to perform analogous abiological C–H functionalization amination and alkylation reactions. Directed evolution of new-to-nature C–C or C–N bond-forming enzymes will enable rapid construction and diversification of chiral bioactive molecules under mild conditions. The proposed research will expedite drug discovery, improve the sustainability of pharmaceutical manufacturing, and contribute to our fundamental understanding of enzyme catalysis and evolution.